Contrast-enhanced ultrasound evaluation of radioembolization treatment response

Project Summary
Hepatocellular carcinoma (HCC) is the third leading cause of cancer mortality worldwide and the incidence is
increasing. The use of transarterial radioembolization (TARE) has been shown to be successful for the treatment
and downstaging of HCC as well as liver metastases. While effective (complete response rates of 25-60%),
evaluation of treatment response is problematic and frequently diagnosed on CT/MRI as equivocal or non-
progressing for the first 4-6 months post treatment using the recently updated liver imaging and data reporting
systems radiation-based treatment response algorithm (LI-RADS Radiation TRA v2024). Importantly, this delay
in definitive diagnosis of tumor viability subsequently delays needed retreatment and can even serve as a barrier
to transplantation.
Contrast-enhanced ultrasound (CEUS) is a well-established technique for enhancing a wide range of vascular
and oncologic ultrasound applications worldwide. Our prior work in HCC locoregional therapy has shown CEUS
provides improved sensitivity in detecting viable tumor following transarterial chemoembolization relative to
traditional cross-sectional imaging and results of our studies served as a foundation for the recently released
CEUS Nonradiation LI-RADS TRA v2024. As part of a recently completed, randomized controlled clinical trial to
use CEUS to augment radioembolization, we observed that changes in tumor vascularity could be detected as
early as one week post TARE and that these changes correlated with longer term response. Consequently, we
propose to evaluate both qualitative and quantitative CEUS as a tool for evaluating HCC TARE, while also
investigating the role of a late phase (Kupffer cell-specific) agent. In the first specific aim we will evaluate the
diagnostic performance of qualitative CEUS to assess treatment response of HCC to TARE at identical time
points obtained on standard of care CT/MRI in a total of thirty patients with treatment naïve HCC. Sensitivity,
specificity, positive and negative predictive value, and reader agreement will then be calculated for each exam
and each time point using explant pathology (when available), or longer-term stability on CT/MRI follow-up as a
reference standard. In the second aim, we will evaluate the diagnostic performance of quantitative CEUS to
assess treatment response of HCC to TARE. Finally, in aim three we will explore the use of a Kupffer cell-
specific contrast agent to improve diagnosis of viable HCC tumor following TARE using the ultrasound contrast
agent Sonazoid
Once fully validated, we expect CEUS to significantly improve treatment response evaluation and provide a
foundation for the development of LI-RADS CEUS Radiation TRA.

Public health relevance
Project Narrative: The use of transarterial radioembolization (TARE) has been shown to be successful for the treatment and downstaging of hepatocellular carcinoma as well as liver metastases. While TARE is an effective locoregional therapy, the limited ability to conclusively diagnose treatment response serves as a barrier to necessary retreatment or transplant in some cases. Consequently, we propose to evaluate both qualitative and quantitative contrast-enhanced ultrasound as a tool for evaluating TARE, while also investigating the role of a late phase (Kupffer cell-specific) agent.